Project 1: Molecular Predictors of Prostate Cancer Progression and Mortality

PROJECT SUMMARY
Prostate cancer (PC) remains a leading cause of cancer-related morbidity and mortality and represents one of
the largest health disparities in the US, with men of African ancestry having the highest incidence and mortality
rates. Additional risk factors for PC include older age, family history of PC, and germline genetics. We previously
reported that rare germline variants in DNA repair genes (gDRG) are enriched in men with lethal/metastatic PC.
We have also developed a novel multi-ancestry polygenic risk score (PRSm) that is highly predictive of PC risk
across diverse populations and associated with a younger age at PC diagnosis and conversion from active
surveillance to treatment. The combined impact of gDRG and PRS on PC progression is not well understood,
particularly in multi-ancestry patients. In this Project, we will use a population-based approach to identify and
recruit diverse, non-European, multi-ancestry PC patients, examine the interplay between rare variants in gDRG
(e.g., BRCA2) with PRSm and the association with PC clinical features. To accomplish this, we will also develop
a clinical-grade paired tumor-germline assay, which will additionally enable large-scale examination of gDRG in
combination with high PRSm using tumor molecular profiles. We will also parse out specific, individual variants
that contribute the greatest effect on a high PRSm, Finally, we will conduct a tailored PC screening clinical trial
for individuals at highest risk of PC due to gDRG and determine patterns of interest, enrollment and adherence
to PC screening. Together, we seek to address and mitigate health care disparities related to prostate cancer
genetics, and the factors influencing clinical implementation. Ultimately, we seek a better understanding of the
interplay between rare gDRG variants and PRSm for a combined analysis of germline genetic information to
improve risk prediction and tailored PC screening for men across a broader populations.

Public health relevance
PROJECT NARRATIVE The goals of this proposal are to use population methods to recruit a diverse cohort of men with incident prostate cancer, perform combined evaluation of rare variant germline DNA repair genes (e.g. BRCA2) and a novel multi- ancestry polygenic risk score, to develop a clinical-grade paired tumor-germline assay and determine the biological significance of high PRSm and specific PRSm variants using tumor molecular profiles. We will also conduct a tailored prostate cancer screening clinical trial including at-risk first-degree relatives of men recruited through population methods and determine patterns of interest, enrollment and adherence to prostate cancer screening. Overall, we seek to investigate the synergy of germline genetic information with relevance to a diverse population with the goal of improving risk prediction and tailored PC screening for men across multi-ancestry populations.